Using deep brain stimulation of the parietal cortex to investigate the electrophysiology of human episodic memory

Project Summary
Our proposal seeks to build upon the success of our lab investigating the electrophysiology of human
memory through novel experiments that will elucidate hippocampal—parietal interactions in memory
processing. The key innovations of this proposal are the application of direct brain stimulation to the
mesial parietal cortex and the adaptation of an associative recognition paradigm to intracranial data.
We will take advantage of our high-volume epilepsy surgical center specializing in stereo EEG
electrode implantation. In our first aim, we will compare how electrophysiological patterns of brain
activation differ between free recall (which comprises the bulk of intracranial memory data) and
associative recognition, specifically examining properties of theta oscillations in the anterior versus
posterior hippocampus. In the second aim, we will apply deep brain stimulation to the mesial parietal
cortex during memory encoding and retrieval, observing differences in memory performance and
hippocampal oscillatory activity that will inform hypotheses of how this area supports episodic
memory. In Aim 3, we will use machine learning classifiers to understand how mesial parietal
stimulation affects memory performance via its impact on brain oscillatory activity in a responsive
stimulation paradigm. These experiments will utilize our lab’s knowledge and infrastructure gained
through participation in the DARPA Restoring Active Memory project. While our proposal is highly
innovative, our center’s proven success in recruiting a large volume of stereo EEG patients for
memory research, data collection, and the application of advanced analytic techniques give us
confidence that we will collect high quality data addressing the critical gaps in the understanding of
human memory.

Public health relevance
Project Narrative Two critical gaps in our understanding of human memory are whether or not hippocampal theta oscillations support encoding in the same manner as in rodents, and the contribution of the mesial parietal cortex in encoding versus retrieval. These questions are closely linked together, and we propose to study them in stereo EEG patients using a novel memory paradigm coupled with deep brain stimulation. Our planned experiments include a closed-loop stimulation paradigm seeking to use parietal stimulation to improve memory performance, the results of which will both inform theories of human episodic memory processing and of the design of therapeutic brain stimulation devices to treat cognitive deficits.